Measuring language comprehension and learning in children with severe cerebral palsy with eye gaze approaches

Project Summary
More than half of all children with cerebral palsy (CP) have communication challenges. A subset has
impairments that are so severe that they lack functional speech. Many also have intellectual disability. Children
with CP and severe speech impairment often have severe gross and fine motor limitations that restrict limb
use. Augmentative and alternative communication (AAC) systems, particularly voice output devices that can be
accessed with eye gaze, can provide crucial access to language for many children. However, our ability to match
language features of AAC systems with language ability profiles of individual children is severely hindered by a
lack of tools to accurately assess latent receptive language abilities in children with severe speech and motor
impairment. AAC technologies currently require sustained eye-gaze for a specified dwell-time to activate word
choices, which can be extremely challenging for children in this population. Innovations in other areas of
language development research have led to the widespread use of eye-gaze techniques to measure receptive
language and learning in other difficult-to-test populations, including infants and autistic toddlers. However,
these techniques have yet to be leveraged to assess receptive language and learning ability in children with CP
and severe speech and motor impairment. Data illuminating children's receptive vocabularies and their ability
to learn new words would provide critical information for identification of an appropriate place to start when
matching language features of AAC systems to underlying language abilities. Our long-term goal is to develop
tools to better characterize receptive language and learning potential in children with CP and severe speech and
motor impairments that can be used to match latent child language skills with language features of AAC
systems. The objective of the proposed research is to begin this process by developing and testing eye gaze
paradigms for use with children who have CP and severe speech and motor impairment. The planned studies
will allow us to determine whether these methods provide more detailed and sensitive information than the
usual behavioral tests. Aims are: 1.) To characterize lexical processing in children with CP and severe speech
impairment using eye-gaze measures; 2.) To investigate novel word learning in children with CP and severe
speech impairment using eye-gaze measures; and 3.) To characterize the relationships between familiar word
processing (Aim 1), novel word learning (Aim 2), and traditional behavioral assessments of child language and
cognitive attainment. This work will advance the development of tools for measuring latent language and
cognitive skills in children with CP and severe speech and motor impairment. The ability to capture underlying
skills at earlier chronological or developmental ages represents a critical advance in the current state of clinical
assessment. Results will lead to a more accurate understanding of language development in children with CP
and severe speech impairment, to the development of more precise AAC interventions, and to theoretical
insights about the relationship between language production and comprehension in children who cannot talk.

Public health relevance
Project Narrative Children with cerebral palsy (CP) have motor problems that affect the entire body, including the muscles used to produce speech. Some children are so severely involved that they are unable to produce speech. These children benefit from augmentative and alternative communication (AAC) technologies to enable them to communicate. Assessing children's language abilities is necessary to determine which AAC system is most appropriate. However, it is very difficult to assess language when children cannot use their hands to point or their speech to answer questions. This project examines the use of eye gaze methods that have been used to study language development in other children including infants and children with autism to determine how well these same methods work for testing language and learning in children with CP. Results will help us develop better assessment methods for matching AAC systems with language needs for children with CP.